FBXL16 as a novel factor in promoting endocrine therapy resistance and metastasis of ER+ breast cancer

Project summary
Endocrine therapy (ET) resistance and metastasis are major obstacles for curing patients with advanced
ERα+ breast cancer (ER+ BC). Upregulated oncogenic ERα activity plays critical role in advanced
progression of ER+ BC. One essential mechanism of regulating ERα signaling is the ubiquitination-
dependent proteasomal degradation of ERα and its co-activators such as steroid receptor coactivator 3
(SRC-3, also known as amplified in breast cancer 1). Owing to its direct effect of targeting ERα for
degradation, fulvestrant is the only FDA-approved selective estrogen receptor degrader (SERD) as a first
line endocrine agent for metastatic and locally advanced breast cancer and a second line drug for
advanced metastatic breast cancer that has progressed after tamoxifen or aromatase inhibitor
treatment. Unfortunately, either de novo or acquired resistance to fulvestrant occurs in the majority of
the patients with advanced ER+ BCs. The molecular mechanism underlying fulvestrant resistance is still
largely unknown. The proposed study aims to test an intriguing hypothesis that the F-Box protein FBXL16
stimulates oncogenic ERα activity by upregulating the stability and expression levels of ERα and
coactivator SRC-3, thereby promoting breast cancer development, metastatic progression and
endocrine therapy (ET) resistance. Two specific aims will be performed. Aim 1 is to determine the roles
of FBXL16 in regulating the stability and expression levels of ERα and ERα LBD mutants; Aim 2 is to
determine the role of FBXL16 in ER+ breast tumor growth, metastasis and endocrine therapy resistance.
By conducting a variety of both in vitro and cell-based assays and in vivo tumor mouse model
experiments, we expect to elucidate how FBXL16 upregulates the protein stability of ERα and ERα-LBD
mutants and to determine the roles of FBXL16 in breast tumor development, metastasis and ET
resistance. Our ultimate goal is to define FXBL16 as a new prognostic marker and/or a therapeutic drug
target for treating advanced ER+ BCs, particularly in the patients with either de novo or acquired
resistance to SERDs including those with ERα LBD activating mutations.

Public health relevance
Project Narrative There is urgent need to identify new therapeutic targets for treating advanced ER+ breast cancer (BC) with endocrine therapy (ET) resistance and/or metastasis. Based on our important findings we postulate that FBXL16, a poorly-studied F-Box protein, promotes ER+ BC development, metastasis and ET resistance by upregulating the stability and expression levels of ERα (both wild type and the ligand-binding domain (LBD) activating mutants) and co-activator SRC-3 and thus the oncogenic ERα signaling. If proven true, our study would advance our understanding of the mechanisms underlying ET resistance and metastasis of ER+ BC, and would provide a rationale to develop novel therapy against FBXL16 for treating advanced ER+ BC, in particular those driven by ERα with LBD activating mutations.